Meiotic Chromosome Inheritance in Caenorhabditis

Program Summary
Our research is aimed at understanding the molecular and cellular mechanisms underlying the faithful
inheritance eukaryotic chromosomes. Our primary focus is on elucidating the events required for the orderly
segregation of homologous chromosomes during meiosis, the crucial process by which diploid germ cells
generate haploid gametes. These events are of central importance to sexually reproducing organisms, since
failure to execute them correctly leads to chromosomal aneuploidy, one of the leading causes of miscarriages
and birth defects in humans. During meiotic prophase, chromosomes undergo a dramatic and dynamic program
of structural reorganization in preparation for the meiotic divisions. Moreover, chromosome inheritance during
meiosis relies on the formation of double-strand DNA breaks (DSBs) and repair of a subset of these DSBs as
inter-homolog crossovers (COs). Because the DSBs that serve as the initiating events of meiotic recombination
pose a danger to genome integrity, the success of genome inheritance during meiosis requires cells to maintain
a balance between the beneficial effects of COs and the potential harmful consequences of the process by which
they are generated. A major goal of our research is to understand the mechanisms that operate during meiosis
to achieve this crucial balance. An inter-related goal is to understand how meiosis-specific chromosome
organization is established, maintained, and remodeled to bring about successful segregation of homologous
chromosomes. We are approaching these issues using Caenorhabditis nematodes, simple metazoan organisms
that are especially amenable to an integrated application of powerful cytological, genetic, genomic, and
biochemical approaches, and in which the events under study are particularly accessible. Our goal under the
MIRA program is to pursue a systems-level understanding of meiosis, based on the recognition that multiple
distinct aspects of the meiotic program are intimately interconnected, and that robustness of the system is an
emergent property of this interconnectedness. Our approach will build on recent technical advances and new
discoveries in the well-established C. elegans experimental system, in combination with opportunities afforded
by a newly-introduced Caenorhabditis interspecies hybrid model, to interrogate the meiotic program at multiple
levels. Planned areas of investigation will include: Elucidating mechanisms that ensure reliable formation of CO-
based connections for all chromosome pairs; Exploring how different events and developmental transitions in
the meiotic program are temporally and spatially coordinated; Investigating the functional organization of
meiosis-specific chromosome structures that promote and regulate meiotic recombination and enable
chromosomes to sense and respond to events occurring at distant positions; Pursuing a new approach aimed at
understanding the fundamental basis of homolog recognition.

Public health relevance
Project Narrative: The proposed research will increase our understanding of the basic mechanisms that promote and ensure the faithful inheritance of chromosomes. The work is highly relevant to human health, as errors in chromosome inheritance are one of the leading causes of miscarriages and birth defects and are also a major factor contributing to the development and progression of cancer. Some aspects of our program will address how repair of DNA breaks is organized and regulated, which is important for maintaining intact chromosomes and for inheriting the correct number of chromosomes. Other aspects will address the physical organization of chromosomes, the spatial relationships between chromosomes, how key events are coordinated during the meiotic program, and how these features contribute to successful inheritance of genomes.